SERVICE RADIATION THERAPY

The objective of this project is to provide expert radiotherapy, consultation, and radiation therapy treatment for Clinical Center patients admitted to services other than the Radiation Oncology Branch of the NCI. Support is given to the Medicine Branch, Surgery Branch, Pediatric Branch, NCI/Navy Medical Oncology Branch, Neurosurgical Service, Endocrine Service, and other Federal Hospitals in the area where technical expertise and technical equipment dictate a need for such consultation.